EFFECT OF INTRAVENOUS PRANLUKAST ON LEUKOTRIENE-D4 INDUCED BRONCHOCONSTRICTION

The cysteinyl leukotrienes are products of the 5 lipoxgenase pathway of arachidonic acid metabolism and are synthesized by mast cells, basophils, macrophages, and eosinophils. The objectives are 1) to determine the effectiveness of 3 different doses of Pranlukast and placebo at inhibiting leukotriene-D4 induced bronchoconstriction, 2) to characterize the relationship between plasma concentrations of Pranlukast and inhibition of LTD4-induced bronchocons, and 3) to evaluate the safety of the various intravenous doses of Pranlukast during inhalation.